Fosinopril analogs for the treatment of human babesiosis

Babesiosis is a malaria-like illness found worldwide and endemic in the United States. The disease is caused
by intraerythrocytic parasites of the genus Babesia. Babesia microti and Babesia duncani, which are
responsible for most cases reported in the United States, are transmitted to humans by Ixodes scapularis and
Dermacentor albipictus ticks, respectively, and can also be introduced by blood transfusion. The current
treatment for human babesiosis consists of combination therapies with atovaquone+azithromycin or
clindamycin+quinine. However, these drugs are associated with high rate of recrudescence, treatment failures
and adverse events. Furthermore, recent studies in mice infected with B. microti and in vitro with B. duncani
showed that these parasites are naturally tolerant to these drugs. These limitations emphasize the need for
more effective and safer therapies for treatment of human babesiosis. We have recently reported the
development of a continuous in vitro culture system for B. duncani in human red blood cells. Using this assay,
we screened a library of FDA-approved drugs and identified fosinopril (the prodrug of the dipeptidyl
carboxypeptidase ACE inhibitor fosinoprilat) as a potent antibabesial inhibitor. The compound was also
effective against both B. duncani and B. microti in mouse models of babesiosis at 10 mg/kg. Interestingly,
neither fosinoprilat nor other ACE inhibitors affected the growth of B. duncani in vitro. Equally interesting,
analysis of the structure of fosinopril and bortezomib (another potent inhibitor of B. duncani identified in the
chemical screen and a known proteasome inhibitor) revealed similarities between the two compounds.
Together these data suggest that the antibabesial activity of fosinopril could be due to inhibition of either an
ACE-like peptidase and/or a proteasome activity of Babesia parasites. The primary goals of this application
are to identify analogs of fosinopril with more potent antibabesial but no ACE activity, and to elucidate the
mechanism of action of these compounds in Babesia parasites. Building upon our preliminary data, we
propose the following three specific aims. In Aim 1, we will determine whether or not the prodrug form of
fosinopril is the active compound, and characterize the efficacy of fosinopril and newly synthesized analogs
against B. duncani and B. microti clinical and field isolates in vitro and examine the structure activity
relationship specific to these parasites. In Aim 2, we will characterize the in vivo efficacy of the most active
compounds alone or in combination with other drugs as a strategy for elimination of Babesia infections. In Aim
3, we will implement biochemical, mass spectrometry and genetic assays to elucidate the mode of action of
and possible mechanisms of Babesia resistance to fosinopril and its analogs. The success of the proposed
three aims will guide future clinical trials to create an ideal regimen for the treatment of human babesiosis with
no recrudescence.

Public health relevance
PROJECT NARRATIVE: Human babesiosis is an emerging and potentially lethal infectious disease caused by eukaryotic pathogens of the genus Babesia. In our search for more potent and safer antibabesial drugs, we discovered that the clinically approved and safe antihypertensive drug fosinopril is a potent inhibitor of Babesia parasites in vitro and in animal models of babesiosis infection. Our proposed studies aim to develop analogs of this drug, determine their mode of action, and conduct efficacy studies to identify candidate drugs that could be advanced toward future clinical evaluation.